Online Courses for Navigating Research Mentoring Relationships

PROJECT SUMMARY / ABSTRACT
Research mentoring relationships are one of the most important means by which students acquire core
research competencies, develop a strong sense of self-identity as a scientist, and prepare for careers.
However, practical training for students in how to initiate and navigate these critical relationships is absent from
most biomedical research training programs. In order to address this discrepancy in training, iBiology will
partner with the authors of ​Entering Research​ at the University of Wisconsin-Madison to build, test, and
evaluate a program of online instruction called “Navigating Research Mentoring Relationships.” This program
will focus on students at the critical undergraduate to graduate transition, i.e., advanced research
undergraduates and first year graduate students. “Navigating Research Mentoring Relationships” will provide
instruction that can be integrated into the curriculum of an existing research training program or engaged with
independently by students in programs that choose not to integrate it, as providing courses online allows the
training material to be accessible regardless of personal or institutional resources. This program will address
challenges that ​students ​from diverse backgrounds face as they transition from undergraduate to graduate
school by (1) teaching them to cultivate mentoring relationships with intentionality and to leverage those
relationships to benefit their education, research, and careers, (2) building a national community of students
from diverse institutions and backgrounds to support their collective learning/training, (3) providing access to
free evidence-based, in depth, just-in-time instruction in their research training, and (4) highlighting important
cultural aspects of responsible conduct of research, reproducibility, and equity and inclusion. The program has
four main aims. First, to develop the “Navigating Research Mentoring Relationships” online course content.
Second, to develop evidence-based strategies to promote student engagement and learning through online
communities. Third, to pilot test “Navigating Research Mentoring Relationships” with undergraduate and
graduate students from diverse backgrounds. And fourth, to revise and disseminate the online courses to the
public. The program will be evaluated using feedback from educational experts, as well as student testing of
the courses and online learning communities at various stages. Evaluation data will include online surveys of
students, course platform analytics, and pilot test site institutional data. The evaluation plan will allow for the
assessment of program outcomes and whether the desired objectives have been met. The evaluation data will
also allow for evidence-based revision and updating of the courses prior to release to the public, where the
courses will be available to biomedical research trainees of all levels. The intended outcomes of this project
are to build the critical interpersonal, communication, and collaboration skills students need to support positive
mentoring relationships and, therefore, increase their persistence in a biomedical research career pathway.

Public health relevance
PROJECT NARRATIVE Many qualified students, especially students from historically underrepresented groups (i.e., women and racial minorities), are choosing not to pursue graduate education in the biomedical sciences, or are leaving biomedical science graduate training programs early, creating a critical deficit in the unique perspectives necessary to perform the innovative research that will benefit the health of our increasingly diverse population . Good mentoring relationships are critical for recruiting and retaining students with diverse backgrounds in science because they provide encouragement, guidance, and social support that enhance student personal and professional development, as well as their integration into the scientific profession. To promote good mentoring relationships, we will build online courses that will empower students with the ability to establish and maintain positive mentoring and collegial relationships shown to be associated with successful biomedical research careers.